PDX Core

Abstract
The goal of the PDX Core is to provide high-quality, clinically relevant, and molecularly annotated PDX models
for the research projects described in the University of Texas PDX Development and Trial Center (UTPDTC)
grant application by leveraging PDX resources at our institutions and developing new PDX models using rigorous
quality standards so that the models can be used to guide clinical trial development. Because of U54 funding
limitations and to keep things as simple as possible, this U54 PDX Core will only function at the MD Anderson
Cancer Center which has more than enough surgical specimens coming in to fulfill the needs of this grant. The
existing UTSW PDX lung cancer models (~40) developed through the NCI SPORE in Lung Cancer
(P50CA70907) will be used by UTSW in Project 1, and new and existing UTMDACC PDX models created by the
PDX Core at MDACC will be supplied to the various projects including for the UTSW component of Project 1.
The PDX models developed and/or characterized under this UTPDTC grant will be available to other cancer
researchers through the NCI Patient-Derived Models Repository and PDX Development and Trial Centers
Research Network (PDXNet). We are in a unique position to provide high-quality PDX models for studies
described in this grant application and for the cancer research community. Our research team has established
506 PDX models from human lung, breast, colorectal, and pancreatic cancers and completed whole exome
sequencing and RNA sequencing for 176 and 94 of these models respectively. We are currently participating in
the NCI's collaborative initiative on PDX models through two separate NCI supplemental awards. We will use
the rigorous quality standards developed by the NCI to generate and characterize PDX models and provide high-
quality PDX models for preclinical investigations. Furthermore, we will enhance the diversity of PDX models for
answering clinical and/or translational questions by leveraging the world-class translational expertise and access
to human tissues unique to our institutions for generating new PDX models. For example, more than 20,000
surgical procedures and 50,000 diagnostic and/or treatment procedures are performed annually at UTMDACC.
Our patient consent forms have already been reviewed by NCI staff and are appropriate for sharing PDXs with
the cancer research community through NCI's Patient-Derived Models Repository and PDXNet. To achieve our
goal of supporting the UTPDTC projects and PDXNet activities, we will provide high-quality clinically and
molecularly annotated PDXs after rigorous quality testing of established PDX models and enhance the diversity
of PDX models by generating and characterizing new models. The proposed study has significant public health
implications because providing the highest quality PDX models for the preclinical investigations described in this
application and to the cancer research community will ultimately improve and accelerate the development of new
effective biomarker-driven cancer therapies, helping cancer patients fight their disease.